Novel Inhibitors of Lysine Methyltransferases G9a and GLP for the Treatment of Alzheimer's Disease

PROJECT SUMMARY
Alzheimer’s disease (AD), the most prevalent dementia, has no effective disease-modifying therapeutics. Our
recent studies have linked abnormalities in lysine methyltransferases G9a/GLP (also known as EHMT2/1) and
histone H3 lysine 9 dimethylation (H3K9me2) to AD pathophysiology. We hypothesize that pharmacological
inhibition of G9a and GLP by small molecules can provide a novel and effective therapeutic strategy for the
treatment of AD. The objectives of this project are: (a) to demonstrate that newly-discovered G9a/GLP inhibitors
are efficacious in AD mouse models; (b) to optimize small-molecule inhibitors of G9a and GLP into a drug
candidate. To achieve these goals, we will pursue three specific aims. Aim 1, assess selectivity, cellular activity
and in vitro ADME (absorption, distribution, metabolism and excretion) and in vivo pharmacokinetic (PK)
properties of lead G9a/GLP inhibitors; Aim 2, evaluate in vivo effects of lead G9a/GLP inhibitors on
normalizing behavioral, synaptic, and transcriptional abnormalities in AD mouse models; Aim 3, Optimize
current G9a/GLP inhibitor leads into a drug candidate by designing, synthesizing and testing novel compounds
to simultaneously optimize potency, selectivity and PK properties. Completion of the proposed studies will not
only validate our therapeutic hypothesis, but also generate a drug candidate that could be ultimately translated
in the clinic for the treatment of AD. The improved G9a/GLP inhibitors generated in this project will also be
invaluable chemical tools for assessing the therapeutic potential of G9a/GLP inhibition in other diseases.

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease (AD) has no effective disease-modifying therapeutics. This proposed research aims to (1) demonstrate that pharmacological inhibition of G9a/GLP can provide a novel and effective therapeutic strategy for the treatment of AD, and (2) optimize small-molecule G9a/GLP inhibitors into a drug candidate . Thus, the proposed research is directly relevant to public health.